Investigating treatment strategies & clinical outcomes of histotripsy for complete ablation of osteosarcoma

Project Summary
Osteosarcoma (OS) is a common and devastating primary bone tumor affecting both humans and canines.
Histotripsy is an emerging non-thermal ablation modality that uses high-pressure focused ultrasound pulses to
induce acoustic cavitation and liquify target tissue with high precision. Our team has pioneered the development
of histotripsy for bone tumors with critical ex vivo and in vivo studies using excised canine OS tumors and pet
dogs with spontaneous OS, respectively. Dogs have an increased incidence of OS with high similarity to human
OS, allowing the pet dog to serve as a valuable comparative oncology model. This proposal seeks to further the
development of histotripsy for OS treatment by 1) investigating the treatment parameters & strategies needed
for complete ablation in ex vivo canine OS, and 2) testing these strategies in pilot clinical trials with acute and
chronic follow-up of pet dogs with histotripsy-treated OS. Throughout these experiments, I will be trained in vital
skills in bio-engineering and clinical oncology, including transmit-receive circuitry (Dr. Tim Hall at University of
Michigan), histopathological analysis of ablation (Dr. Sheryl Coutermarsh-Ott at Virginia-Maryland College of
Veterinary Medicine), and radiological assessment of ablation (Dr. Tim Ziemlewicz at University of Wisconsin).
The results of this work will overcome previous technical & engineering barriers in achieving complete ablation
of bone tumors and will provide crucial safety & feasibility data to guide and inform the clinical translation of
histotripsy as a non-invasive limb salvage treatment for OS.

Public health relevance
Project Narrative Osteosarcoma is a devastating and highly metastatic bone cancer that causes pain and mortality and histotripsy, a novel ablation modality using high-intensity focused ultrasound, shows promise in both destruction of the primary tumor and induction of an anti-tumor immune response to combat metastatic disease. Our group has validated the safety & feasibility of ablating portions of osteosarcoma tumors with histotripsy, but crucial studies investigating the required treatment parameters and the clinical outcomes of complete ablation of osteosarcoma are needed to further the clinical translation of histotripsy for the treatment of bone tumors. My proposal tackles these questions in order to assess the safety & feasibility of histotripsy for the complete ablation of osteosarcoma.